IU Training Program in Molecular Physiology and Clinical Mechanisms of Lung Disease

PROJECT SUMMARY / ABSTRACT
This application, currently in the 10th year, is a competitive renewal of the “Training Program in Molecular
Physiology and Clinical Mechanisms of Lung Disease”, which is implemented as a Combined Adult and
Pediatrics Pulmonary Research-training program at Indiana University (CAPPRI). The program is unique in
synthesizing the adult and pediatric Pulmonary Divisions to examine diseases across the lifespan. Our mission
is to train exceptional MD and PhD scientists for leadership in investigative careers. In order to position the future
generation for this goal, our training program (CAPPRI) is designed to enable Trainees to have a comprehensive,
integrative, and formal career development experience with the goal of positioning them to become the next
generation of leaders in Pulmonary and Critical Care research. The CAPPRI stresses translational science,
incorporating the newest scientific platforms and didactic training integrated with cell, animal model, and human
tissue research with established clinical research programs. Formal graduate school training is available through
the Indiana Clinical and Translational Sciences Institute (CTSI). There are 33 Faculty Mentors and 7 Emerging
Mentors from 9 Departments. The inclusion of 7 emerging mentors (EM) is to provide the continuum of
mentorship and leadership development for the CAPPRI. CAPPRI is designed around selected Thematic Affinity
Groups (TAGs). The five TAGs include: 1) Vascular Biology, including both adult and pediatric presentations of
disease; 2) Outcomes and Health Services; 3) Airway Biology encompassing the continuum of the lifespan; 4)
Inflammation, Injury and Repair; and 5) Developmental Mechanisms. For a sustainable workforce, we will use a
conceptual model of academic persistence as our theoretical framework. Between 2009-2019, 22 T32 Trainees
were supported, with 18 completing their training. 83.3% remain in academic medicine or related research fields.
The group has published 147 peer-reviewed works. This group has been awarded 25 grants, including 8
fellowship awards, 5 career development awards, and 3 NIH R01 awards. The Trainees are highly diverse, with
50% women. All of these factors enable the Indiana University to be an ideal site for training future leaders in
respiratory diseases across the lifespan.

Public health relevance
PROJECT NARRATIVE Pulmonary diseases account for approximately four million deaths per year in the United States. There is an acute need to train dedicated scientists who will form the future workforce empowered to make discoveries which lead to the reduction in death and disability from pulmonary disease. The Indiana University School of Medicine “IU Training Program in Molecular Physiology and Clinical Mechanisms of Lung Disease,” provides state-of-the-art research training for M.D. and Ph.D. scientists, adult and pediatric, in both laboratory-based and clinical studies, with the goal of training the next generation of leaders in the field of pulmonary disease research across the lifespan.